The Pro-Inflammatory Effects of Acute Exercise in Children with Sickle Cell Anemia (Diversity Supplement - Olorunyomi - UIC)

This section is not applicable to this application.

Public health relevance
This section is not applicable to this application.